Deconstructing Disparities in Lupus Pregnancies

PROJECT SUMMARY / ABSTRACT
In a disease like systemic lupus erythematosus (SLE) that primarily affects women of childbearing age, social
determinants of health (SDOH) and clinical factors significantly impact adverse pregnancy outcomes (APOs).
While race has been recognized as a pivotal SDOH in APOs in SLE, there is a dearth of data regarding the
influence of other SDOH. The objective of this mentored patient-oriented research career development award
is to determine the contribution of SDOH to the risk of APOs in SLE. The central hypothesis is that multiple
discrete SDOH contribute to risk of APOs in SLE patients. The primary outcome is a combination of fetal
morbidity and CDC-defined maternal morbidity, and the secondary outcome is a combination of in-hospital
maternal and fetal mortality. With the Candidate’s experience in health disparities research and her mentoring
team’s expertise in SLE, qualitative research and machine learning, the Candidate will test the hypotheses with
the following aims: 1) To quantify the associations and interactions of race and income with APOs in patients
with SLE; 2) To identify important neighborhood-level SDOH associated with APOs in patients with SLE; and
3) To determine the ability of individual-level SDOH in predicting APOs in patients with SLE. The Candidate will
use US nationwide data (~51,000 SLE pregnancies) and machine learning in data from five distinct and
geographically diverse US states to determine the association between race and neighborhood-level income,
as well as understand the impact of other neighborhood-level SDOH on APOs in patients with SLE. Further,
she will collect both prospective individual-level SDOH data at two New York centers and perform qualitative
interviews with stakeholders (recently pregnant patients with SLE, rheumatologists, high-risk obstetricians, and
social workers) to contextualize the results and to elicit unmeasured SDOH. Through the strategic utilization of
multi-dimensional data, at the end of this project, Dr. Bella Mehta (awardee) will have identified the most
meaningful SDOH that contribute to APO risk in SLE both at an individual- and community-level. Over the
course of this mentored research career development award, Dr. Mehta will obtain advanced training in the
application of established and innovative methods for machine learning, acquire a broad understanding of the
concepts and methods of qualitative research, and develop proficiency in assessment of reproductive health
policies and programs. Data and skills from this study will provide the foundation for an R01 to disentangle the
role of different SDOH in SLE pregnancy outcomes and develop a robust risk prediction tool in large SLE
cohorts and other rheumatic conditions. Thus, patients who need intervention can be identified early, and
future strategies and policies can be developed and implemented to reduce health disparities and improve
outcomes in individual patients.

Public health relevance
PROJECT NARRATIVE The objective of this Mentored Patient-Oriented Research Career Development Award is to determine the contributions of social determinants of health to the risk of adverse pregnancy outcomes in systemic lupus erythematosus, while gaining the skills and training to become an independent investigator. By skillfully integrating diverse data sources, we will identify the most meaningful social determinants of health that contribute to adverse pregnancy outcomes risk in patients with systemic lupus erythematosus both at an individual and community level. This innovative approach combines clinical factors with social determinants of health and stakeholder feedback to create a synthesis that will streamline the identification of at-risk patients, with the long-term goal of mitigating health disparities and improving pregnancy outcomes for those grappling with this disease.